Redox regulation of protein functions linked to neurodegeneration

Project Summary/Abstract:
The molecular and metabolic mechanisms that go awry during the course of neurodegeneration
remain poorly understood. A conserved protein called ataxin-2 has been linked to
neurodegeneration due to the occurrence of polyglutamine tract expansions that can influence
the aggregation of itself and other proteins. However, the normal functions of this protein and
the consequences of their alteration have not been clear. It was recently shown that the protein
can function as a redox sensor to then regulate cellular metabolism and signaling in a manner
that sustains mitochondrial health and cell survivability. This proposal will investigate aspects of
the mechanism of redox sensing by ataxin-2 in both yeast and mammalian cells, the
downstream outputs, as well as the consequences of mutations and variants on associated
cellular functions.

Public health relevance
Project Narrative: We plan to investigate a conserved protein involved in sensing the redox and metabolic state of cells and neurons. Mutations in this protein have been linked to mitochondrial dysfunction and neurodegenerative disease. We hope these studies will provide key insights into the mechanisms leading to neurodegeneration and reveal innovative therapeutic strategies for the treatment of such conditions.